PGpR2 Supplement for Continuation of the Scientific Data Research Center (SDRC) of the Gastroparesis Clinical Research Consortium (GpCRC)

Project Summary/Abstract
This proposal from the Johns Hopkins University is to continue as the Scientific Data Research Center
(SDRC) to the Gastroparesis Clinical Research Consortium (GpCRC), sponsored by the National Institutes of
Health since 2006, to support the pediatric clinical centers as they continue to collect data and biospecimens
for participants ages 8-24 with symptoms of gastroparesis to create a Pediatric Gastroparesis Registry 2. The
SDRC aims for the expansion of the Pediatric consortium are: 1) To develop and conduct a new pediatric
gastroparesis and functional dyspepsia registry of patients with symptoms of gastroparesis; and 2) To
coordinate and implement use of a single IRB (sIRB) to oversee all participating pediatric centers.
The SDRC will provide leadership, expertise in biostatistical analysis, study design, data system design
and management, multicenter coordination, quality assurance, project support, communication and
organization, and will be responsible for supporting all future protocol development or modifications, including
providing sample size calculations, statistical advice, forms development, data analysis and manuscript
preparation. The SDRC will support development, implementation, maintenance, and data monitoring of a real-
time database of clinical information for the PGpR2 study, prepare de-identified databases to submit to the
NIDDK Central Repository for public-use and maintain a digital repository of procedure output and specimen
assay or genomic data. The SDRC will prepare all performance and data monitoring reports for committees
including the Steering and Executive Committees, DSMB, and ad hoc reports that may arise. The SDRC will
prepare protocols or future protocol changes for submission to the SC, NIDDK program office, and Data and
Safety Monitoring Board (DSMB), along with regulatory documents and reports in support of Investigational
New Drug (IND) or Investigational Device Exemption (IDE) applications on behalf of the NIDDK. Synergistic
partnerships between GpCRC investigators and expert scientists to use biospecimens, and clinical meta-data
to advance the understanding of the determinants of the pathogenesis and progression of gastroparesis will be
supported by the SDRC. The SDRC will collaborate with the clinical centers to coordinate procedures for
preparation, coding, and shipping of clinical center biospecimens to the NIDDK Central Repository and work
with the Repository to manage the receipt and inventory of biospecimens and de-identified Public-Use data for
storage in the NIDDK Central Repository and fulfilling investigator specimen and data requests. The SDRC will
manage the development, approval, and amendments of GpCRC policy statements, SOPs, ancillary studies,
presentations, and publications.

Public health relevance
Project Narrative Gastroparesis is a disorder of gastric function characterized by delay in gastric emptying and frequently associated with chronic nausea and vomiting, early satiety, and abdominal pain, and can have a devastating impact on quality of life. The Pediatric Gastroparesis Registry 2 aims to expand on the first registry of pediatric patients with symptoms of gastroparesis for the enhanced study of symptoms, gastric motility abnormalities, patient characteristics, and degree of morbidity. This cohort will be followed to further define the natural history and clinical course of pediatric patients with symptoms of gastroparesis, and will provide a source for recruitment for other studies, including therapeutic clinical trials, pathophysiological, molecular, histopathologic, or other ancillary studies.